Role in pathogenesis and parasite cell biology of the trans-sialidase from Trypanosoma cruzi, the agent of Chagas Disease

Project Summary
Chagas disease affects an estimate of 1,600,000 people in Argentina. This chronic disabling
disease also constitutes a major health issue in Latin America. Its causative agent, the protozoan
flagellate Trypanosoma cruzi, expresses a virulence factor known as trans-sialidase (TS) that cover
the inability of the parasite to perform sialic acids synthesis de novo. TS transfer the sialyl residue
from the mammal host proteins to the parasite surface, thus preventing its lysis by serum components
and enabling the parasite to invade cells where to replicate. This virulence factor is also shed to the
milieu being found in the bloodstream thus acting far from the infectious site/s. TS induce several
alterations on the immune system including apoptosis of cellular components and modulation of CD4
T cells both at their elicitation and effector stages. We recently defined the distribution of the parasite
surface protein components where the TS and mucins, the main acceptor of the sialyl residue
transferred, are located in separate domains. Similarly happens with other unrelated proteins.
Some proteins use the contractile vacuole as a pathway to reach the surface while others not. In this
project, we propose to study the protein requirements to use this trafficking pathway, or been excluded
from it, and the process associated with their final fate on different domains at the parasite surface.
Because the TS constitute a central virulence factor of the parasite we will obtain parasites devoid of
its expression to assess their ability to invade cells, replicate and induce pathogenesis in mammals.
The ability of TSs to modulate the TH1/TH2/TH17 balance will be analyzed at the light of recent
findings from our lab that might explain previous results from other researchers and been associated
with the outcome of the infection.

Public health relevance
Project narrative The trans-sialidases (TS) from Trypanosoma cruzi are virulence factors strongly involved in the parasite cell biology, invasion and pathogenesis. The TS parasite surface distribution and shedding requirements will be disclosed together with that for other proteins, particularly mucins. The TS relevance in the parasite cell biology and pathogenesis, particularly its involvement in the T cell phenotype balance will be disclosed.